Focused Ultrasound Therapies for the Non-Invasive Treatment of Tendinopathies

PROJECT SUMMARY
Achilles tendinopathy is a disabling, often painful condition that can progress to further degenerative
tissue changes or result in tendon rupture if not effectively managed. It is widely held that therapeutic mechano-
transduction processes promote healing of the injured tendon. Clinical ultrasound therapies deliver energy in
the form of propagated sound waves to targeted tissues. However, current therapeutic ultrasound treatments
commonly provide minimal mechanical stimulation of the injured tendon. Focused ultrasound (FUS) is an
emerging, non-invasive therapy capable of inducing bio-effects through mechanical and/or thermal mechanisms
with high spatial and temporal precision. Recent pre-clinical tendon models have demonstrated the potential of
FUS to achieve mechanical fractionation with no deleterious effects on tendon function or healing; however, no
studies have investigated FUS as a rehabilitative loading treatment for tendinopathy.
The primary objectives of this study are to (1) utilize numerical modeling to establish FUS protocols for
precise acoustic stimulation of murine Achilles tendons, (2) identify FUS stimulation parameters for effective in
vivo treatment of murine Achilles tendinopathy, and (3) characterize the cell and matrix responses associated
with distinct FUS stimulation regimes. We will first develop an integrated computational modeling - experimental
approach to characterize ex vivo tendon temperature changes and mechanical strain under a range of FUS
treatment parameters (Aim 1). Protocols developed in Aim 1 will then be applied towards in vivo FUS treatments
of injured tendons, with healing assessed using biomechanical, histologic, and cell biologic outcomes (Aim 2).
We hypothesize that (a) the application of FUS will augment healing of injured Achilles tendons, and that (b)
mechanical FUS regimes will be more effective than thermal FUS regimes.
Successful demonstration of the potential of FUS to stimulate tendon healing will considerably strengthen
the rationale for using FUS as a non-invasive, rehabilitative treatment method for tendinopathy and provide
encouraging evidence of a potentially effective alternative over existing ultrasound therapies for tendon injuries.
Furthermore, our project will generate novel insights into the relationships between acoustic stimulation
parameters and tendon mechanotransduction. Finally, this project will establish a modular, scalable
experimental platform upon which future studies in larger species and/or different tendon types can readily be
undertaken.

Public health relevance
PROJECT NARRATIVE Therapeutic ultrasound has shown modest efficacy in the treatment of human tendinopathy. This project will develop a computationally driven, focused ultrasound (FUS) experimental methodology to investigate the effects of thermal and/or mechanical FUS pulsing protocols on the healing profile of murine Achilles tendons.